Collaborative for REsearch to Advance TMD Evidence (CREATE)

We propose to finally bridge the gap in our understanding of the relationship between
temporomandibular disorder (TMD) pain and underlying mechanisms, which will provide new
diagnostics and therapeutics for TMD patients. We envision that the TMD Collaborative for
Improving Patient-Centered Translational Research (TMD IMPACT) will address the need for:
TMD prevention, the development of effective and personalized TMD therapies, and expanding
the current work force of those researching and managing TMD pain by taking a bidirectional
translational approach. Our vision for TMD IMPACT involves five key components: 1) a Clinical
Phenotyping Core responsible for Clinical Centers across the US, to coordinate patient
assessment and analyses, ensure clinical studies include whole-person evaluations of
individuals with a TMD, the collection of phenotypic data that will be used to identify TMD
subtypes and biomarkers predictive of underlying mechanisms, and patient outcomes and
response to therapeutic interventions; 2) a Preclinical Core responsible for the validation of
preclinical models, establishing causal links between mechanisms and pain phenotypes, and for
the initial efficacy, specificity, and safety testing of therapeutic interventions; 3) a Data and
Biospecimen Management Core that will coordinate the integration of different data types and
storage of biospecimens, such that TMD IMPACT resources follow FAIR principles and provide
long-lasting impacts on TMD research into the future; 4) an Education and Outreach Core to
build scientific and clinical workforce capacity, thereby increasing the number of programs
pursuing preclinical and clinical TMD research, expanding the availability of evidence-based
care for people living with a TMD, and promoting dissemination and implementation of
advances made by the Collaborative; and 5) a Stakeholder Group consisting of patients/patient
advocates, payers, and industry representatives who will provide feedback on all Collaborative
efforts. During the proposed planning phase, our Collaborative for REsearch to Advance TMD
Evidence (CREATE) team will work with the other selected teams to lay the groundwork needed
to establish the TMD-Collaborative and achieve a shared vision for TMD-IMPACT. Our general
strategy will be to engage with funded sites and centers chosen for the TMD-IMPACT planning
phase, as they will have expertise and infrastructure relevant to the four core components of the
Collaborative.

Public health relevance
The many mechanisms that lead to temporomandibular disorders (TMDs) remain poorly understood, which has negatively impacted TMD prevention and the development of evidence- based treatments. We envision that the TMD Collaborative for Improving Patient-Centered Translational Research (TMD IMPACT) will address the need for: TMD prevention, the development of effective and personalized TMD therapies, and expanding the current workforce of those researching and managing TMD pain by taking a bidirectional translational approach. Our vision for TMD IMPACT involves five key components: Clinical Phenotyping, Preclinical Research, Data and Biospecimen Management, Education, and a Stakeholder and Engagement Group.